Distinct roles of U2AF1 mutations in myelodysplastic syndrome pathogenesis

PROJECT SUMMARY/ABSTRACT
This proposal outlines a 5-year training plan for the transition of the candidate to an independent investigator.
The long-term goal of the candidate is to be a physician-scientist at an academic medical center studying the
molecular basis of genetic mutations in myelodysplastic syndrome (MDS) pathogenesis, in addition to directing
a molecular pathology laboratory. The training plan proposed will expand upon the candidate's clinical and
scientific background and provide him access to a supportive environment that will prepare him for a career as
an independent investigator. The applicant will be mentored by Dr. Matthew Walter, an expert in MDS genetics
and biology and Director of the Edward P. Evans Center for MDS at Washington University (WU). An advisory
committee consisting of basic science and clinical/translational MDS experts and pathologists will provide
scientific and career advice. The applicant's laboratory is well equipped for these studies, and WU provides a
rich environment for training and development as access to core facilities, scientific resources, and clinical
samples is exceptional. The experiments outlined in this application aim to clarify the distinct roles of different
U2AF1 mutants in MDS pathogenesis, as highly recurrent heterozygous mutations in splicing factor genes (e.g.,
U2AF1) occur in over half of MDS patients. Hotspot mutations in U2AF1 (encoding U2AF1S34 and U2AF1Q157
mutants) are associated with different clinical features, outcomes, dysregulated RNA splicing, and co-occurring
gene mutations in patients with MDS. For example, truncating mutations in ASXL1 cooccur more frequently with
U2AF1Q157 than with U2AF1S34 mutations in MDS patients. The candidate has observed U2af1S34F/+ and
U2af1Q157R/+ conditional knock-in mice develop different hematopoietic phenotypes, including cytopenias, and
have distinct gene expression patterns and aberrant RNA splicing in hematopoietic stem and progenitor cells
(HSPC). This proposal aims to understand how the distinct molecular perturbations induced by U2AF1S34F and
U2AF1Q157R mutants contribute to the divergent hematopoietic phenotypes observed in MDS patients by
determining: (1) how activation of MYC and mTORC1 pathways leads to HSPC dysfunction and multilineage
cytopenias in U2af1S34F/+ mice and whether U2AF1S34F-specific splicing alterations result in activation of these
pathways, and (2) how mutant ASXL1 and U2AF1Q157 associated histone modification and RNA splicing
aberrancies selectively cooperate in MDS pathogenesis. Deciphering the role of MYC and mTORC1 activation
will allow these models to be used to test pathway-specific therapeutic strategies to alter cytopenias, and
identification of cooperation between ASXL1 and U2AF1 mutations in vivo may reveal novel mechanisms by
which RNA splicing and histone modifications synergize in MDS. In sum, the proposed studies and training
environment will facilitate the candidate's success in becoming an independent investigator.

Public health relevance
PROJECT NARRATIVE Hotspot mutations in the U2AF1 splicing factor gene (encoding U2AF1S34 and U2AF1Q157 mutants) are associated with different clinical features, outcomes, alternative splicing, and co-occurring gene mutations in patients with myelodysplastic syndromes (MDS). The proposed studies will test the hypotheses that different gene expression and alternative splicing programs are aberrantly induced by U2AF1S34F and U2AF1Q157R mutants, and that these distinct molecular perturbations contribute to the divergent hematopoietic phenotypes we observe in MDS patients, including cooperativity with other gene mutations (e.g., ASXL1). A better understanding of the mechanisms driving pathogenesis of U2AF1 mutant MDS could nominate vulnerabilities to therapeutically exploit in MDS patients harboring mutations in U2AF1 and other splicing factor genes.